ANALYSIS OF T CELL RECEPTOR STRUCTURE AND FUNCTION

White blood cells called T lymphocytes play critical roles in immune defense against viruses, bacteria, fungi, protozoa, and cancer cells. They are also involved in allergies/asthma due to the development of an unwanted or excessive type of immune response to substances in our environment and in autoimmune diseases that result from the inappropriate attack of these cells on the body's own tissues. The effector functions of T cells are mediated largely by proteins termed cytokines that either be expressed at the cell surface or secreted. Because T cells see foreign substances (antigens) in the form of peptide-major histocompatibility complex (MHC) molecule complexes on cell surfaces, we wish to know how such complexes interact with specific receptors to evoke the effector activities of mature T cells in the body, as well as regulate their growth, inactivation, or death. In particular, we want to understand in molecular detail the protein-protein interactions that turn recognition of antigen by T cells into signals guiding the function of these cells, how variations in these recognition and signaling events leads to desirable versus undesirable forms of immunity, and how we can manipulate these events to augment useful immune responses and inhibit damaging ones. Our most recent studies in this area deal with two new classes of T cell stimuli called partial agonists and antagonists, which this laboratory helped discover. We are investigating the detailed biochemistry of signaling inside of T cells exposed to these novel stimuli and have demonstrated changes in early events termed tyrosine phosphorylation when using partial agonists or antagonists rather than complete agonists. Our work has helped define these altered signaling events in both CD4+ and CD8+ T cells of mouse and man. We have examined the relationship between these altered signaling patterns and the induction of T cell unresponsiveness [anergy] or the selective productive of cytokine effector molecules. These data are revealing the mechanisms involved in antigen-dependent T cell activation and providing possible avenues for manipulation of specific immunity through the use of altered T cell receptor ligands.